Transposon mutagenesis of Rickettsia for studying Rickettsia-host-vector interactions

Abstract
Rickettsia is a genus of arthropod-borne pathogens responsible for typhus and spotted fever diseases. Hallmark
of Rickettsia is their reductive genome evolution, obligate intracellular lifecycle within vascular endothelial cells,
immune escape in the bloodstream, and transmission via blood-feeding arthropods, with Rickettsia replicating
in the gastrointestinal tract or salivary glands of their various vectors (e.g., lice, ticks, mites, or fleas). Recent
environmental and sociological changes have supported the invasion and expansion of arthropod vectors into
new geographical areas, prompting healthcare alerts for the increasing arthropod-borne rickettsial infections.
Owing to the technical difficulties of isolating, propagating, and genetically manipulating Rickettsia, early work
studied rickettsial virulence mechanisms by expressing target genes in heterologous organisms (such as
Escherichia coli) or characterizing rickettsial variants with different genetic backgrounds. While these studies
identified putative virulence genes, they failed to address the biological functions involved in rickettsial
pathogenesis, transmission, and host immunity against typhus and spotted fever diseases. To explore the
genetic bases of rickettsial pathogenesis, recent studies developed genetic tools for Rickettsia and characterized
rickettsial variants. These investigations characterized several Rickettsia mutants with defects in actin-based
motility, O-antigen synthesis, and cell-to-cell spread. Nevertheless, genes underpinning rickettsial entry into
vascular endothelial cells, intracellular immune evasion and replication, release and survival in the bloodstream,
or replication in various cell types of their arthropod vectors remain largely uncharacterized. This application
describes an in vitro transposition reaction using purified Tn5-transposase complexed with the kkaebi mini-
transposon, which provides for chloramphenicol selection of Rickettsia variants with single chromosomal
insertions. DNA sequencing of insertion sites demonstrates the random nature of insertional mutagenesis with
the kkaebi-transposon, while chloramphenicol-selection allows for facile isolation of variants that can be analyzed
for in vitro replication as well as defects in the pathogenesis and transmission. In the first phase (R61) of this
application, kkaebi variants will be generated using two model organisms of pathogenic Rickettsia (R. conorii
from the spotted fever group and R. typhi from the typhus group). After the successful completion of the first
phase, kkaebi variants will be characterized for phenotypic alterations using biochemical and molecular
analyses, tissue culture infections, tick infection models, and mouse infection studies. Overall, this work will
generate key experimental resources for the research community to comprehensively identify rickettsial genes
essential for pathogenesis and transmission by arthropod vectors.

Public health relevance
Narrative Arthropod-borne rickettsial species are a major cause of emerging febrile illnesses with significant public health and economic impacts; however, our understanding of the genetic bases for rickettsial pathogenesis, vector transmission, and protective immunity is limited. This application aims to generate kkaebi transposon mutant libraries for two model organisms of pathogenic Rickettsia species belonging to the spotted fever and typhus groups, enabling investigators to identify essential genes for Rickettsia. Further, this application will characterize virulence genes and their biological functions, specifically focusing on those genes involved in O- antigen biosynthesis.